Role of Protein Arginine Methyltransferase 9 in Acute Myeloid Leukemia Maintenance

Project Summary
Acute myeloid leukemia (AML) is a deadly disease. Although cytogenetic and molecular risk-adapted
approaches can guide treatment, overall outcomes remain poor. Currently available cell cycle-based
chemotherapy or targeted therapy, such as use of tyrosine kinase inhibitors (TKIs), cannot eliminate all leukemia
clones. Mounting evidence suggests that remaining cells that depend on oncoproteins for survival become a
source of relapse. Many of these oncoproteins, such as Mcl-1, STAT5, and c-Myc, are short-lived, and their high
levels in tumors are likely due to aberrant activation of the translation machinery, a hallmark of cancer. Thus,
understanding mechanisms underlying dysregulated translation is necessary to antagonize leukemia
persistence. We recently found that higher expression levels of PRMT9, the most recently defined symmetric-
dimethylarginine (SDMA)-forming enzyme, are associated with decreased overall AML patient survival. Our
proteomics and mutagenesis analysis revealed a novel mechanism whereby PRMT9 catalyzes methylation of
translation elongation factor eEF1A1, linking PRMT9 to active translation and promoting AML maintenance.
Accordingly, PRMT9 inhibition blocked AML cell survival/proliferation in an eEF1A1 methylation-dependent
manner, while sparing normal hematopoietic cells. Inhibition of PRMT9/eEF1A signaling indeed decreased
protein biosynthesis, reducing levels of the short-lived oncoproteins Mcl-1, c-Myc, and STAT5 and significantly
extending leukemic mouse survival. Thus, we hypothesize that PRMT9 is critical for AML pathogenesis and that
PRMT9-mediated eEF1A methylation promotes mRNA translation and protein synthesis to enable AML
maintenance. To test this hypothesis, we will: 1) define the function of PRMT9-mediated eEF1A arginine
methylation in AML pathogenesis using a MLL-AF9-related doubly-hit AML mouse model and a newly developed
PRMT9 conditional knockout mouse; 2) define molecular mechanisms underlying PRMT9/eEF1A signaling in
AML by testing whether eEF1A methylation alters its GTPase activity by enhancing GTP/GDP binding and
assessing whether PRMT9 deficiency induces global translation changes in AML based on ribosome profiling
sequencing; 3) determine combined effects of PRMT9 deletion or inhibition with daunorubicin/cytarabine or
AC220 treatments on AML eradication in murine and human AML models. Our studies should reveal functional
interaction between PRMT9 and eEF1A and indicate how arginine methylation of highly conserved eEF1A R166
governs translation in cancer cells. These studies will close the knowledge gap relevant to how leukemia cells
acquire a survival/growth advantage through aberrant activity of the translation machinery and may show how
combining targeting of PRMT9 with current treatments could represent a more effective strategy to eliminate
AML cells.

Public health relevance
Project Narrative Understanding how leukemia cells hijack the translation machinery to allow high expression of short-lived oncoproteins is critical to develop effective therapies to treat this lethal blood disease. Recently, we identified a novel regulatory axis in AML in which PRMT9 overexpression induced eEF1A1 arginine methylation to promote AML cell maintenance. In this project, we will evaluate the functions of PRMT9 activity and eEF1A1 arginine methylation in human AML patient specimens and genetic mouse models with a goal of developing novel AML therapies based on PRMT9 inhibition.